Placental Genomics in the Developmental Consequences of Marijuana Use in Pregnancy

PROJECT SUMMARY/ABSTRACT
This application is responsive to NOT-DA-20-039: Effects of Cannabis Use and Cannabinoids on the Devel-
oping Brain. Prenatal cannabis use is common and increasing, with rates as high as 1 in 4 in poor, young,
underserved women. Expanding legalization of cannabis has led to increasing availability, use, perceptions of
safety as well as increased potency. However, data is lacking regarding the impact of prenatal use of increase-
ed-potency cannabis on offspring neurodevelopment. Our group is currently conducting an intensive, prospective
investigation of the impact of maternal prenatal cannabis use on infant neurodevelopment (R01DA044504). Our
ongoing study has yielded preliminary evidence for an impact of prenatal cannabis on offspring growth and
neurodevelopment, but does not involve a comprehensive interrogation of genomic pathways underlying these
associations. Pinpointing genomic pathways will allow us to identify biomarkers of fetal harm and develop
novel screening tools and intervention targets to protect and treat exposed offspring. The placenta is a
unique organ that regulates the intrauterine environment, maternal-fetal communication--including passage of
cannabinoids--and plays a critical role in supporting fetal growth and neurodevelopment. Seminal work by our
group has revealed that the prenatal environment impacts placenta function, that alterations in placenta function
can be informed by genomic profiling of the placenta, and that alterations in placenta genomic profiles are linked
to newborn growth and neurobehavior. MicroRNAs (miRNAs) are an understudied aspect of placenta epigenetic
regulation; miRNAs are short non-coding RNAs that regulate gene expression post-transcriptionally and are crit-
ical regulators of placental- and neuro-development. A recent initial study supports the hypothesis that maternal
cannabis may impact placenta immune gene networks, and offspring anxiety, but was not designed to investigate
prenatal cannabis, only included a small number of cannabis users, and did not include miRNA. We propose a
comprehensive placenta miRNA and mRNA profiling study to define the impact of prenatal cannabis
exposure on placenta genomic activity and infant neurodevelopment. We test the central hypothesis that
prenatal cannabis exposure leads to unique alterations in placenta endocannabinoid, neuronal development,
immune, and stress signaling pathways, and that these functional genomic features will also impact infant de-
velopment. We leverage our ongoing cohort (n=100 cannabis users, n=100 non-users) designed to assess the
impact of prenatal cannabis on infant neurodevelopment and including placenta collection for candidate methyl-
ation assays. Our proposed genomic mechanisms study involves the addition of state-of-the-art whole transcrip-
tome RNA-sequencing (mRNA and miRNA) to delineate the functional impacts of prenatal cannabis exposure
and links to infant development. Determining genomic profiles underlying the impact of prenatal cannabis on
infant development is timely and offers potential to identify biomarkers of exposure and offspring risk as well as
molecular targets for future intervention efforts.

Public health relevance
PROJECT NARRATIVE Despite increasing prevalence and potency of marijuana use in pregnancy in the US, little is known regarding biological pathways underlying its impact on offspring neurodevelopment in humans. We propose to compre- hensively interrogate the genomic features of the placenta--a key organ which regulates the in utero environ- ment--to elucidate biological pathways underlying the impact of prenatal marijuana on newborn growth and neu- rodevelopment. Results from this study offer potential to (a) identify high-risk groups, (b) identify new biomarkers of exposure and fetal harm, and (c) identify novel molecular targets for intervention efforts to improve pregnancy and long-term offspring health outcomes.